A Compact Hybrid Magnet with High Homogeneity for X-Band DNP/NMR and EPR Spectroscopy

Project Summary / Abstract We propose to develop a 0.35 T compact and portable hybrid magnet with high homogeneity (< 2 ppm) and ± 0.05 T of sweep range. The magnet system will be used in Overhauser Dynamic Nuclear Polarization experiments in the X-Band for studying water dynamics in molecules and other analytical chemistry applications. In Phase I, we will design, build and test a prototype magnet to meet the above stated requirements. We will characterize the magnet by measuring the field homogeneity using a three-axis Hall probe as well as conducting control NMR measurements with a micro-sample to prove that the system achieve 2 ppm homogeneity necessary to resolve the spectral lines of interest in an X-band ODNP experiment. In a future Phase II project we will develop a compact ODNP spectrometer using this magnet and other subsystems that have proved to be commercially successful.

Public health relevance
Narrative The proposed research focuses on the development of a compact, hybrid magnet with high homogeneity for DNP-NMR/EPR spectroscopy in the X-Band. DNP enhances the inherently small signal intensities observed in a NMR experiment by up to two orders of magnitude, dramatically increasing the overall sensitivity of the method and reducing the data acquisition time. This is of high interest for NMR methods for pharmaceutical and analytical chemistry research; areas that are of significant interest to research funded by the U.S. National Institutes of Health.